Translational Investigation of XPO1 Inhibition in High-Grade Glioma and Diffuse Intrinsic Pontine Glioma

Abstract Pediatric high-grade glioma (HGG), including diffuse intrinsic pontine glioma (DIPG), represent the most common cause of cancer death in children. Aside from radiation therapy (RT), few effective treatment options exist. This is especially true for DIPG, in which hundreds of chemotherapy clinical trials have failed to improve outcomes. One potential issue is that systemically-delivered medications cannot penetrate DIPG. Both HGG and DIPG overexpress Exportin 1 (XPO1), which controls the nuclear export of tumor suppressor proteins. Selinexor is a selective XPO1 inhibitor that has shown a strong antitumor effect in patient-derived DIPG cell lines and patient-derived HGG cell lines and murine xenograft (PDX) models. It has a good safety profile in adults and is currently the subject of a phase 1 trial in children, with a focus on recurrent non-DIPG HGG. In vitro results show that the mechanism of action of XPO1 inhibition in HGG appears to depend on NGFR induction, resulting in NF-κB suppression. Selinexor appears to synergize with proteasome inhibitors against HGG/DIPG. It also represents a candidate drug to study the pharmacokinetics (PK) of systemic chemotherapy in DIPG for the first time. The hypothesis of this project is that XPO1 inhibition will synergize with proteasome inhibition and radiation therapy (RT) to suppress NF-κB, leading to apoptosis, but selinexor cannot adequately penetrate DIPG to achieve therapeutic effect through systemic delivery. In this project, HGG/DIPG laboratory models will be used in combination with samples from ongoing clinical trials to achieve maximum impact. First, selinexor's interaction with NGFR and NF-κB will be elucidated using PDX models validated in pediatric HGG clinical trial tissue. Next, the therapeutic relationship of XPO1 inhibition with proteasome inhibitors and RT will be measured using cell culture and PDX models, with a focus on the effect on NF-κB. Finally, the pharmacodynamic (PD) effects and PK of selinexor will be compared between DIPG and HGG clinical trial tumor specimens, and DIPG/HGG PDX tumors. This translational laboratory work during clinical investigation will help optimize the use of XPO1 inhibition as a strategy to improve treatment for pediatric HGG and DIPG patients. The educational aims of this project tie directly to the research aims. They include improved understanding of basic science in molecular biology techniques, hypothesis investigation, and data analysis. All of these will be key to the pathway investigation and complex comparison of cancer model and human tumor data central to this project. Completion of this project will produce strong career development, leading to an independent career using translational research to improve patient outcomes in pediatric HGG and DIPG.

Public health relevance
Narrative High-grade glioma and diffuse intrinsic pontine glioma are aggressive brain tumors representing the most common cause of childhood cancer mortality. In this project, the novel treatment strategy of XPO1 investigation will be investigated in these diseases to determine how the strategy can best be utilized to improve outcomes for these patients. The aims include study of the mechanism of action, combination therapy, and pharmacokinetics, making use of cell culture and animal models, as well as current clinical trial specimens.